IDENTIFICATION AND DELIVERY OF CLINICAL DRUG CANDIDATES

Identification and delivery of clinical drug candidates through the performance of studies required for the advancement of drug discovery projects within the NCI Experimental Therapeutics (NExT) Program.